Translational Neuroscience and Neurotechnology Training (TNNT)

Abstract
Advanced studies in neuroscience increasingly require sophisticated mathematical and
computational skills in addition to a strong knowledge base in neurophysiology. Likewise, novel
treatments of neurological diseases often require problem solvers (i.e. engineers) with both
advanced computational skills as well as a solid foundation in systems neuroscience. The
fundamental premise of this training program is that early engagement of computationally strong
students, principally engineers, in understanding fundamental mechanisms of neuroscience will
accelerate development of technology and solutions for the diagnosis and treatment of stroke,
Parkinson’s disease, amyotrophic lateral sclerosis, traumatic brain injury, pain, epilepsy,
paralysis, and other neurodegenerative disorders. With long-established research experience in
these disorders existing at Washington University in St. Louis, we propose a training program that
will develop common skill sets in engineering doctoral students towards solving difficult problems
in neural engineering. Graduates of this novel training program will have the knowledge and
expertise to pursue either an academic research career and/or a private sector research career
in neurotechnology. We request support for four predoctoral students in the proposed five-year
program. Cohorts will include five total predoctoral positions, each of two years in duration.

Public health relevance
Project Narrative The fundamental premise of this training program is that early engagement of computationally strong students, principally engineers, in understanding fundamental mechanisms of neuroscience will accelerate development of technology and solutions for the diagnosis and treatment of stroke, Parkinson’s disease, amyotrophic lateral sclerosis, traumatic brain injury, pain, epilepsy, paralysis, and other neurodegenerative disorders. Graduates of this novel training program will have the knowledge and expertise to pursue either an academic research career and/or a private sector research career in neurotechnology.